Protocol Review and Monitoring System

PROTOCOL REVIEW AND MONITORING SYSTEM: PROJECT SUMMARY
The Siteman Cancer Center Protocol Review and Monitoring Committee (PRMC) serves in the capacity of
Protocol Review and Monitoring System as mandated by the NCI. It has operated under continuous NCI approval
since 2001, and it fulfills the NCI expectation that all NCI-designated cancer centers scientifically evaluate and
prioritize all cancer center trials derived and supported from institutional sources (including those originating from
other cancer centers) or from industry. In 2018, the committee met 33 times and reviewed 183 protocols, of
which 52 were investigator-initiated protocols; an additional 239 protocols were reviewed administratively by a
co-chair. PRMC also provides a mechanism for monitoring all cancer research studies at the institution for
scientific progress, carrying with it the authority to close any studies that are not making sufficient scientific
progress or meeting accrual or performance standards. Committee members have expertise in all relevant
disciplines, with reviewers from Medical Oncology, Radiation Oncology, Surgical Oncology, Bone Marrow
Transplant, Gynecologic Oncology, Pediatric Oncology, Radiology, Pathology, Psychology, Public Health
Sciences, Behavioral Sciences, Biostatistics, Pharmacy, and Protocol Development.
Improvements made over this cycle include:
 Workflow streamlining and automation through leveraging features of the OnCore Clinical Trials
Management System;
 Enhanced efficiency through elimination of redundancies in the submission process, including
superfluous submission documents;
 Increased consistency between PRMC and WU IRB submissions;
 Standardization of investigator-initiated studies following implementation of review by the Siteman
Cancer Center Protocol Development team as part of PRMC.